Biorepository of iPSC lines from diverse rat strains for regenerative medicine research

Abstract: The use of the laboratory rat (Rattus norvegicus) has been critical for biological research in diverse fields such as physiology, pharmacology, cell biology, immunology, toxicology, nutrition, and behavior. Furthermore, it is the preferred species for disease modeling and as a platform for the development of novel therapeutics. Of the many rat strains, Sprague Dawley (SD), Lewis (LEW/SsNHsd), Long-Evans, Fisher 344 (F344), and immunodeficient athymic nude (Hsd:RH-Foxn1rnu ) rats are the most popular ones for biological studies. In 2008, three groups established chimera- and/or germline-competent rat embryonic stem cells (rESCs). In addition, based on the ground-breaking work by Yamanaka and colleagues to reprogram somatic tissues to ESC-like induced pluripotent stem cells, several groups including ours reported on the generation of rat induced pluripotent stem cells (riPSCs) from SD somatic tissues. While this iPSC technology has been revolutionizing biomedical research and the study of regenerative medicine, it is still in its early stage (a decade-old) and significant efforts are required to improve our understanding of reprogramming and to advance its technology. For instance, it is well documented that individual human ESC and iPSC lines exhibit remarkably different propensities in their differentiation properties and that iPSC lines retain certain level of “epigenetic memory”, directly affecting differentiation properties. At present, comparative analyses of genomic, epigenomic, transcriptomic, metabolic, and differentiation properties of riPSCs from diverse rat strains are lacking. Our multidisciplinary team proposes the following 4 Specific Aims over the next 4 years: Aim 1: Generation and characterization of multiple riPSC lines from three popular tissues of SD rats: rat embryonic fibroblasts, neural precursor cells and peripheral blood mononuclear cells using conventional and our novel reprogramming methods. Aim 2: Global genomic, epigenomic, and transcriptomic status using state-of-the-art methods. Aim 3: Establish authentic riPSC lines from Lewis, Long-Evans, F344, and athymic rats using our novel and optimized reprogramming methods. All genomic data for each riPSC line will be shared with academic community. Aim 4: Assessment of the immunogenicity of riPSC-derived tissues in syngeneic and allogeneic hosts using in vitro analyses and in vivo transplantation studies. In summary, this R24 will establish well-validated and viable riPSC lines along with their comprehensive biological and genomic characteristics.

Public health relevance
Narrative: The laboratory rat (Rattus norvegicus) has been used as an essential animal model for biological and medical researches over 150 years using diverse strains including the most popular strains such as Sprague Dawley (SD), Lewis (LEW/SsNHsd), Long-Evans, F344, and immunodeficient athymic nude (Hsd:RH-Foxn1rnu ) rats. To facilitate stem cell-based regenerative medicine research, our multidisciplinary team proposes to establish an optimal reprogramming methods and to generate multiple rat induced pluripotent stem cell (iPSC) lines from these diverse rat strains for comparative analyses of their genomic, epigenomic, transcriptomic, metabolic, and differentiation properties, and to investigate their epigenetic memory and immunogenicity. Thus, this R24 grant will establish a biorepository of high quality rat iPSC lines from multiple rat strains that will be widely available to a broad scientific community with their in-depth biological and bioinformatics analysis.